Molecular and Computational Dissection of Cold Nociception

Project Summary / Abstract
The long-term goal of this project is to elucidate the basic cellular, molecular, and physiological mechanisms of
cold nociception. Thermosensory nociception is a specialized form of somatosensation, essential to the survival
of all metazoans, that alerts the organism to potential environmental dangers coupled with pain sensation thereby
serving as a protective mechanism for driving adaptive behavioral responses to safeguard against incipient
damage. Despite this importance, the fundamental cellular, molecular, and physiological bases of cold
nociception remain incompletely understood. Molecularly, transient receptor potential channels (i.e.
thermoTRPs) play critical roles in thermosensation either by direct or indirect activation in response to
temperature change, however, the mechanisms by which cold temperatures are transformed into ion channel
structural alterations to regulate neural activity remain unclear. Similarly, relatively less is known regarding how
thermoTRPs may interact with other sensory transduction receptors and downstream signaling pathways to
mechanistically regulate cold detection. Neurologically, acute and chronic pain may manifest as altered
thermosensory nociception whereby thermal stimuli erroneously engage nociceptive circuitry leading to
neuropathic pain. Cold allodynia or hyperalgesia are well-known symptoms of inflammatory and neuropathic
pain that have been associated with peripheral nerve injury, multiple sclerosis, fibromyalgia, stroke, and
chemotherapy-induced peripheral neuropathy, however, the mechanisms underlying cold sensitization are poorly
understood. Here, we will investigate how noxious cold stimulation exerts cellular and physiological effects on
membrane properties, cytoskeletal dynamics, and mechanosensory ion channel function. Further, we will
characterize non-canonical roles of sensory transduction receptor signaling in regulating cold nociception. Using
Drosophila as a model system, we will bi-directionally link experimental and computational approaches involving
neurogenetics, high-resolution cellular imaging, in vivo functional imaging, electrophysiology, behavioral assays,
and computational biophysically-grounded modeling. The project aims and outcomes of this research will
significantly advance our knowledge of cold nociception by addressing three open questions: (1) How do
changes in the mechanical and fluidic properties of the membrane and cytoskeleton contribute to cold-evoked
behavior? (2) How do mechanoreceptor channels contribute to cold somatosensation? (3) How does a
heterogeneous population of sensory transduction receptors, including non-canonical receptor channels and G-
protein coupled receptors (GPCRs) contribute to cold sensation? More generally, the bi-directional integration of
experimental and computational approaches in a closed-loop investigational strategy is well-suited to transform
our understanding of cold nociception by elucidating potentially generalizable mechanisms of cold coding,
including biophysical impacts of cold and conserved transduction machinery.

Public health relevance
Project Narrative The perception of noxious thermal stimuli is often coupled to pain sensation as a protective mechanism, however, aberrant temperature sensation can lead to neuropathic pain (e.g., in peripheral nerve injury; multiple sclerosis; fibromyalgia; stroke; and chemotherapeutic-induced peripheral neuropathy) where patients experience pain due to cold hypersensitivity. By uncovering basic biophysical, cellular, and molecular mechanisms of noxious cold perception, we develop critical insights into neural integration of painful/nociceptive stimuli providing potential routes for understanding and treating neurological disease when this process is disrupted.